Kansas University Training Program in Neurological and Rehabilitation Sciences

PROJECT SUMMARY
Funds are requested for the third cycle of the Kansas Training Program in Neurological and Rehabilitation
Sciences. The aim of the program is to provide interdisciplinary practical training and theoretical instruction in
translational research in basic and clinical aspects of neuroscience, especially as it applies to neurological
conditions amenable to rehabilitative treatments. The interdisciplinary nature of this offering is unique in that
basic science trainees participate in clinical aspects of neurological disorders and clinical trainees are exposed
to laboratory research and basic neurobiological mechanisms. The training program utilizes basic science and
clinical research expertise of the faculty to cross-fertilize the training experience. Didactic training includes core
curricula for predoctoral students in the Integrated Graduate Program in Biomedical Science, the Graduate
Program in Neuroscience, the MD/PhD program, the Graduate Program in Rehabilitation Science, and the
Graduate Program in Bioengineering, providing a firm groundwork for understanding basic genetic, molecular
and cellular mechanisms. Besides the two to three years of support offered to full-time trainees, short-term,
summer training experiences are offered to medical and health professions (Doctorate in Physical Therapy)
students. The summer training program is designed to expose clinical students to the complex interdisciplinary
approaches needed to maximize neurorehabilitation approaches. The summer research experience has made
the short-term trainees more competitive for top flight residencies, and inspired health professionals to alter
their career path to develop into clinician-scientists. The predoctoral preceptors area composed of 15 basic
science and clinical mentors, along with 28 short-term mentors and administrative faculty. The mentors are
located within 13 academic departments in the School of Medicine and the School of Health Professions at the
University of Kansas Medical Center, and the College of Engineering at the University of Kansas-Lawrence.
The strength of this group is evidenced by the expertise and caliber of the research faculty, the outstanding
research infrastructure, the focus on translating basic neuroscience discoveries into treatments for neurological
disorders, and the collaborative interactions between the basic and clinical faculty that are needed for an
effective interdisciplinary training program. Laboratory research and apprenticeships, courses, seminars, guest
lectures, journal clubs, data sessions, and poster presentations are included in the program to ensure frequent
interactions between the trainees and faculty. A new feature of the program in this cycle is a more formal
relationship with the Bioengineering Graduate Program, allowing us to provide bioengineering mentors and
engineering content to our required course in Neurorehabilitation. The recruitment and selection of trainees is
overseen by an Internal Advisory Committee, with input from the participating faculty. In addition, the program
is monitored by an External Advisory Committee composed of national leaders in graduate training in
neuroscience, rehabilitation science and bioengineering.

Public health relevance
PROJECT NARRATIVE This unique program provides interdisciplinary predoctoral training for future basic and clinical scientists in the rapidly evolving field of neurorehabilitation. The program will help ensure that both bench scientists and health care workers are prepared to fully and rapidly exploit the exciting new discoveries now emerging in this dynamic field. Effective treatments for neurological conditions will only be developed through interdisciplinary team science as modeled in this program.